CARBOHYDRATE AND GLYCOPROTEIN DIGESTION IN CYSTIC FIBROSIS

The purpose of our research is to determine the role of pancreatic function in modulating intestinal permeability to carbohydrates. We have demonstrated that measurement of lactulose permeation is a sensitive index of pancreatic function in CF.